"Role of Amplified Protein Kinases in Head and Neck Squamous Cell Carcinoma Progression and Therapy Resistance."

ABSTRACT
Head and neck squamous cell carcinomas (HNSCC) are the sixth most frequent cancer, but treatments for
HNSCC are still limited. Current management of HNSCC often involves surgery and chemo-radiotherapy, the
latest alone or combined with cetuximab, an EGFR-targeting monoclonal antibody, or immune checkpoint
inhibitors. These regimes usually concur with comorbidities such as jaw stiffness, dysphagia, and swallowing
and speech impairments, and HNSCC are often refractory to existing treatments.
Chromosome copy number variations (i.e., gain or loss of chromosome regions) are the most common genetic
alterations in HNSCC; one of the most prevalent is the `3q amplicon', i.e., the amplification of the distal segment
of chromosome 3. To identify alternative targets for intervention in HNSCC, we have scanned for protein kinases
within the `3q amplicon'. We recently defined amplified TNIK, a serine/threonine protein kinase encoded within
the `3q amplicon', as a promising target in lung squamous cell carcinoma (LSCC). We found that TNIK inhibition
suppressed the growth of LSCC patient-derived xenografts. Consistently, in HNSCC cell lines with TNIK
amplification, inhibiting TNIK reduced HNSCC cell viability. Mechanistically, TNIK promotes LSCC cell viability
by activating the focal adhesion kinase (FAK) and the YAP and TAZ (YAP/TAZ) transcription factors. FAK and
YAP/TAZ are frequently aberrantly activated in HNSCC, and these two pathways are known to contribute to
HNSCC progression and therapy resistance in multiple tumor types. Given that TNIK is amplified in 20% of
HNSCC and its downstream effectors activated, we propose a model in which amplified TNIK is an oncogenic
driver that activates essential signaling pathways responsible for controlling cell viability and promoting therapy
resistance in HNSCC. To test this model, we propose two Specific Aims. In Aim 1, we will test whether TNIK
sustains HNSCC cell proliferation and viability by activating FAK and YAP/TAZ. In Aim 2, we will investigate
whether and how inhibiting TNIK sensitizes HNSCC cells to chemotherapy and EGFR-targeting monoclonal
antibodies in HNSCC cells. We will test these two aims by using a combination of cell-based proliferation and
survival assays, coupled with pharmacological and genetic approaches to target TNIK, FAK, and YAP/TAZ.
These studies will identify new mechanisms of HNSCC progression and chemoresistance. This proposal will
enable us to generate new hypotheses for a competitive R01 application to study the consequences of targeting
TNIK in preclinical models of HNSCC in alignment with our long-term goal of identifying new therapeutic targets
for intervention in HNSCC.

Public health relevance
PROJECT NARRATIVE Head and neck squamous cell carcinomas are the sixth most frequent cancer. Treatments for this tumor type are limited, and head and neck squamous cell carcinomas are often resistant to existing treatments, which limits patient benefit. Defining mechanisms of head and neck squamous cell carcinoma progression and therapy resistance has the great potential to unveil novel therapeutic targets to serve patients with head and neck squamous cell carcinomas.